Admin Core

Duke Cancer Institute Administration supports the Duke Cancer Institute's Executive Director, senior leaders, program leaders, shared resource leaders, and members to ensure strong service interactions and communications between all constituents across the research, clinical, education, community engagement and outreach areas. DCI leadership creates the overall strategic direction and research mission for DCI and DCI Administration operationalizes their vision. DCI Administration's mission is to promote all activities including strategic planning and coordinated, transparent and exceptional operations that serve the high-level scientific goals of the DCI. The DCI Administration team oversees all research administration, clinical research, financial resources, human resources, strategic planning, community engagement, outreach, communication, philanthropy, informatics and IT operations, training and education within the DCI. DCI Administration plays a major leadership role in DCI Strategic Planning processes and in implementing strategic initiatives. Accomplishments over this grant period include the 2022-2027 DCI Strategic Planning process, the Shared Resource `Horizon Planning' effort, reorganization and expansion of the administrative team to improve operations, reorganization of research programs, and appointment of new senior leaders across multiple research programs, shared resources and services. DCI was able to grow its cancer research activities with continued institutional support from Duke University Health System and School of Medicine, including over $17.9 million to support operational infrastructure, $46 million in recruitment funds, and protected academic time for DCI faculty. During the project period, over $131 million in philanthropic support was provided to the DCI by a dedicated Development team, including over $30 million in FY2023 alone. DCI Administration supported training, educational lectures, seminars, supplementary educational activities and fellowship grants. In addition, DCI Administration launched Research Logix to support Administration and CRTEC to improve operational efficiency. Tableau Dashboards were implemented to support COE and clinical research. DCI launched and supports multiple new multidisciplinary initiatives, such as the Center for Brain and Spine Metastasis, Duke Sarcoma Center, and Center for Cancer Immunotherapy. The DCI Administration serves 357 members, 12 shared resources, and seven programs across 33 academic departments within eight schools at Duke University and oversees over 230 non-clinical staff to support the academic mission. DCI Administration directly manages over $109.8 million in annual operating funds, of which $15.8 million is philanthropic funds, directly supporting CCSG research programs, shared resources and the clinical research office. In addition, DCI Administration supports the clinical trials activities of DCI members currently funded by 619 grant awards and clinical research contracts amounting to $238 million, and over 105,000 sq. ft of research, office and shared resource space.